Binocular Coordination of Eye Movements

Abstract
High visual acuity, binocular alignment and binocular coordination of eye movements are important in foveate
species and are susceptible to visual development disruptions leading to enormous negative impact on public
health and the economy. Thus, developmental loss of sensory or motor fusion leads to ocular misalignment
(strabismus) and associated binocular oculomotor disturbances in as much as 5% of all children and
amblyopia is the leading cause of monocular visual impairment in the U.S., disabling over two million children.
In Aim 1, we investigate how strabismic subjects orient their eyes to visual targets within their environment. We
will build upon our recent work, recording from the superior colliculus in non-human primate models for
strabismus, that has focused on a curious gaze orienting behavior, wherein under binocular viewing, many
strabismic subjects choose their eye of fixation depending upon location of the eccentric visual target. In the
proposed experiments, we will investigate the contribution of a critical area for visual target selection, the
Frontal Eye Fields and use a unique stimulus (the double-step paradigm) to test the validity of a competition
framework as the basis for gaze orienting behavior in alternating strabismus. In Aim 2, we will test, in the
monkey, an innovative new therapeutic approach to treat MD amblyopia that has demonstrated remarkable
recovery of vision in the MD eye, involving temporarily inactivating the fellow eye by intravitreal injection of a
low volume of low concentration tetrodotoxin (TTX). If TTX therapy were shown to be an effective and safe
substitute for patching therapy, it would foster a revolutionary advance in treatment of amblyopia. Following
induction of amblyopia via MD in infant NHP, TTX will be injected into the vitreous cavity of the good eye.
Rigorous vision testing will be performed after MD to establish the severity of amblyopia and repeated after
TTX treatment to test treatment efficacy. Within this specific aim, we will also determine whether TTX
microinjection is safe and has no permanent effects on eye function or structure. Our approach to investigating
parameter space will include experiments in animals at two ages (within and outside the critical period), at two
dosage levels and with two frequencies of application. Control experiments will include sham injections and a
reverse occlusion cohort. Before and after each round of TTX injection, visual function testing will be
conducted, including visual acuity evaluation via VEP or CSF testing, testing of stereo function, evaluation of
the pupil, refraction, ERG, bio-microscopy, biometry, and OCT retinal nerve fiber layer/optic nerve imaging.
Finally histologic evaluation of the eyes will evaluate any evidence of TTX-induced damage and histological
evaluation of brain will evaluate support for amblyopia recovery. Thus, each of the two aims leverage our
unique expertise in working with monkey models for visual development disorders and is likely to significantly
advance understanding of mechanisms underlying neural circuitry. Moreover, this project has the potential to
help guide the development of rationally based therapies for amblyopia.

Public health relevance
PROJECT NARRATIVE Ocular misalignment (strabismus) and compromised visual acuity (amblyopia) are visual developmental disorders that affect a vast number of children born every year in the United States and around the world. Prior to application of treatment in humans, a better understanding of neural mechanisms and pre-clinical testing in non-human primate models are needed to help develop and refine rationally based therapy. This project will a) combine various physiological methods and behavior investigation in an animal model for strabismus to investigate how gaze is re-oriented to visual stimuli and b) develop and test in the non-human primate, a novel treatment strategy for amblyopia that has shown promise in cat and mouse models.